Integrated frameworks for single-cell epigenomics based transcriptional regulatory networks

PROJECT SUMMARY
Transcription factors (TFs) compose a subset of proteins that regulate the expression of a wide range of genes
in cells. Instructing many tissue- and cell-type specific gene expression programs in the body, transcriptional
regulation is one of the major mechanisms of cell differentiation and polarization induced by TFs. Understanding
the dynamics of transcriptional regulation is crucial since it is a critical component of cell, tissue, organ and
system development and its dysregulation can lead to many complex diseases. Transcriptional regulation is best
modeled via directed networks in which the edges originating from transcription factors to their downstream
targets represent regulatory relationships. However, building, optimizing and analyzing transcriptional regulatory
networks (TRNs) is highly challenging due to inherent complexity of such networks. Moreover, the dynamic wiring
in these networks evolves over time during cell and tissue differentiation and presents a continuous trajectory,
instead of discrete states. Current approaches for understanding this dynamic system are mainly based on gene
expression and are underpowered to accurately model such networks because alterations in gene regulation
often take place via changes in chromatin architecture. Further, existing methods either disregard or oversimplify
the heterogeneous nature of network states in cell populations, thereby leading to a loss of resolution. In this
proposal, we hypothesize that continuous cell differentiation trajectories are driven by evolutions in the
transcriptional network wiring, which are induced by alterations in the chromatin architecture. Our overarching
goal in this research program is to elucidate the continuous evolution of regulatory wirings associated with
developmental stages or disease conditions using cell-specific TRNs that are constructed from single-cell
epigenomic data. To reach this goal, we will build TRNs using motif analysis coupled with multiple single-cell
epigenomic sequencing data, including chromatin accessibility (ATAC-Seq), DNA methylation (BS-Seq), histone
modification (ChIP-Seq) and three-dimensional chromatin interaction (Hi-C) at single-cell resolution. We will use
these networks to uncover the regulatory changes associated with cell differentiation and discover the key
transcriptional regulators that drive the cells along developmental trajectories or across the disease states. We
will also detect transcriptional regulatory modules within these networks to discover pathways associated with
cell differentiation. Finally, we will apply our approach to multiple domains and test our hypothesis using biological
models. Altogether these studies will establish a system of dynamic network models for unraveling epigenetic
regulation at a high resolution. This integrated set of models will not only facilitate an accurate understanding of
epigenetic regulation in development but will also be a powerful asset for discovering targets for therapeutic
interventions for a wide range of complex diseases associated with transcriptional dysregulation.

Public health relevance
PROJECT NARRATIVE Activity of most genes in mammals are controlled by transcription factor proteins, which activate and suppress their target genes via epigenetic regulation without changing the DNA sequence. This regulation is best modeled by network models with directed edges from transcription factors to their target genes and many developmental processes and complex diseases are associated with dysregulation in these networks. In this proposed research program, we will develop a set of frameworks to model transcriptional regulatory networks at the cellular level with epigenetic data and use them to discover key regulators and therapeutic targets.